Native Alzheimer Disease Resource Center for Minority Aging Research (NAD-RCMAR)

LEADERSHIP AND ADMINITRATIVE CORE ABSTRACT
The Native Alzheimer’s Disease Resource Center in Minority Aging Research (NAD-RCMAR) will be directed by
two Principal Investigators: James E Galvin, MD, MPH a Professor at the University of Miami Miller School of
Medicine who is internationally recognized for his research, experience, mentoring, and leadership in the area
Alzheimer’s disease and related dementias (ADRD), brain health and resilience, and recruitment and research
efforts in health disparities in URM populations including American Indian/Alaska Native (AI/AN) and Native
Hawaiians/Pacific Islanders (NHPI) communities, and Patrik Johansson MD, MPH (Cherokee and African
American ancestry) an Associate Professor of Medicine at the Elson S Floyd College of Medicine at Washington
State University (WSU) is a former NAD-RCMAR Scientist developing national reputation for exploring root
causes of health disparities in AI/AN and NHPI communities. The Leadership and Administrative Core (LAC) will
provide day-to-day and long-term direction and support for Pilot Studies, RCMAR Scientists, and the Analysis
Core. The Specific Aims of the Core are to: (1) Support budgetary, logistical and field operations across
academic sites, including coordination of meetings and travel, and facilitate interactions with the Satellite
Centers; (2) Oversee a plan for supervision, implementation, management, organization, and communication of
key strategic decisions, research regulatory processes, and data sharing plans that stimulates, coordinates,
integrates, and monitors activities and functions across the all Cores, NAD-RCMAR faculty, mentors, NAD-
RCMAR Scientists, and all affiliate institutions; (3) Collaborate on program planning, review, and evaluation to
ensure that NAD-RCMAR achieves its goals and maintains its focus on research in ADRD-related health disparities
and mid- and late-life risk and resilience factors affecting brain health and ADRD; (4) Solicit and review Pilot Study
applications and monitor the progress of NAD-RCMAR Scientists in their conduct of Pilot Studies and assisting
NAD-RCMAR Scientist to overcome barriers to success; (5) Convene the Executive Committee, the External
Advisory Committee, the Publications and Presentations Committee, and the Data Safety and Monitoring Board;
and (6) Regularly interact with the RCMAR Coordinating Center and other RCMAR programs, including shared
tasks to advance NIA and the RCMAR program goals and objectives. The LAC Core will be jointly led by Drs.
Galvin (contact PI) and Johansson, who will be responsible for overall planning and coordination, including
budget preparation, oversight of personnel and other aspects of management and operation. Together, Drs.
Galvin and Johansson will promote collaborations among ADRD researchers, AI/AN and NHPI communities,
Satellite Centers, and NAD-RCMAR Scientists to facilitate an integrated approach to NAD-RCMAR’s research
goals. Together with the LAC Core staff, the Principal Investigators will facilitate an integrated approach to NAD-
RCMAR’s research goals and ensure the successful implementation of NAD-RCMAR efforts.